DNA double-strand break chromatin alterations and genome integrity

Acquisition of a fluorescent microscope for genetic interrogation of DNA damage
responses
Project Summary/Abstract:
Alternative lengthening of telomeres (ALT) is poorly understood homology directed repair
mechanism that is responsible for telomere maintenance in ~15% of human cancers. We have
developed systems that enable quantitative, real-time visualization of each step during ALT. Our
published studies from this R01 reveal that ALT is initiated by DNA damage dependent clustering
of telomeres into nuclear bodies that serve as hubs for long tract homology directed repair
synthesis. We named this mechanism Break Induced Telomere Synthesis and showed that it is
critical for telomere lengthening in cells that utilize ALT.
To examine the question of how DNA damage responses assemble on telomeric chromatin, we
coupled synchronous telomere DNA double-strand break induction with telomere purification to
identify the telomere DNA damage response proteome. This revealed a hybrid damage response
that consists of both homology directed DNA repair and replication stress factors. We hypothesize
that ALT occurs by assembling elements of several different DNA repair mechanisms on telomeric
chromatin to achieve long tract homology directed repair synthesis. Our preliminary data reveals
that responses that either promote or inhibit ALT. To systematically address this response, it is
essential for us to perform loss of function experiments that allow us to quantitatively assess the
importance of each factor during ALT. The overall goal of this proposal is to perform arrayed
CRISPR screens that target each factor in the telomere damage response. We will visualize the
effect on ALT by quantifying EdU colocalization at telomeres in G2 as a marker of recombination
dependent telomere maintenance. This is a known hallmark of ALT. We will use the Cas9 system
that allows guide RNAs targeted to functional domains in each gene. The screen will be performed
in unperturbed ALT cells and following TRF1-FokI induction, which is a telomere specific nuclease
that generates DNA double-strand breaks at telomeres that promote ALT. Imaging will be
performed in an arrayed format on a Nikon Ti2E motorized inverted microscope that is equipped
with the capacity to image either live or fixed cells with a 40X objective in a 96 well format. These
fundamental studies will allow us to define the critical elements of the telomere DNA damage
response and how it allows telomere lengthening for sustained proliferation in cells that rely on
ALT.

Public health relevance
Narrative My research program is devoted to understanding fundamental DNA repair mechanisms and their influence on cancer etiology and response to therapy. We will continue to approach these central questions by utilizing unique systems that we have developed to investigate the molecular events underlying (1) the influence of chromatin on DNA repair mechanism, and (2) interactions between repair mechanisms that affect genome maintenance. Incorporation of high content microscopy- based screens will provide insights into noncanonical homology directed repair mechanisms that are used by cells to maintain telomere length.